Epigenetic and transcriptional mechanisms driving human pigmentation diversity

Melanin is the key determinant of human pigmentation that has evolved under natural selection and has led to
diversification of human skin color. Importantly, the number of melanin-producing-melanocytes and their
anatomical location do not vary among humans, only varying melanogenesis determines the human
pigmentation diversity. Our long-term goal is to build a comprehensive understanding of the epigenetic and
transcriptional machinery that dictate precise human melanogenesis gene expression programs that governs
normal-range human pigmentation variation and disease susceptibility. The key insights about human
melanogenesis have come from mapping genes involved in hypo- and hyper pigmentation diseases, Genome-
wide Association Studies (GWAS) of normal-range skin and hair color variation in human populations and genetic
studies on mouse coat color. Nonetheless, current genetic knowledge can explain only a fraction of skin color
variation in humans suggesting that many loci controlling pigmentation remain unknown. By conducting a
genome-wide CRISPR screen, PI has uncovered novel candidate genes driving human pigmentation. Among
the novel pigmentation genes identified, we found that KLF transcription factors are differentially expressed in
light and dark colored human melanocytes and play an antagonistic role in melanogenesis in a gene dosage
dependent manner. We will investigate the cellular and molecular mechanisms of these closely related factors
to understand their roles in human pigmentation variation. Consistent with other human phenotypes, we
hypothesize that most DNA variants driving normal-range human pigmentation and skin disease susceptibility
may lie in non-protein-coding regions of genome. We will map the cis-regulatory landscape of melanocytes from
diverse color humans by performing unbiased epigenomic profiling to uncover putative enhancers with divergent
gene regulatory activity. We will prioritize the candidate divergent enhancers for functional analysis by focusing
on loci that have either previously been associated with skin color GWAS studies or overlap with novel
melanogenesis genes identified by our genome-wide genetic screen. Through genetic perturbation studies we
will confirm whether cis-regulatory changes affect gene expression quantitatively. Building on PI’s postdoctoral
work, over the next five years, the lab will combine diverse approaches to understand the genotype-to-phenotype
connection in human skin pigmentation variation. These approaches include pluripotent stem cell differentiation
models that recapitulate human melanogenesis in vitro, genome-engineering, massively parallel reporter assays,
single-cell profiling methods, quantitative melanin measurements, and validation experiments in transgenic
mouse models. Through our studies on a highly quantifiable trait such as melanin, we will provide insights into
how genotypic variation encoded in genome give rise to differences in gene expression and leads to phenotypic
divergence within human species, which has implication for human development, health and disease.

Public health relevance
Skin color is genetically derived traits that is highly variable between human subpopulations and is determined by the quantity, type and distribution of melanin pigment. Variable melanin production by skin pigment cells not only drives skin color variation but also contributes to differential disease susceptibility among humans. This proposal seeks to understand the epigenetic and transcriptional mechanisms that govern variable melanin production resulting in human pigmentation diversity and has implications for human evolution, health and disease.